IgA Nephropathy: Impact of EBV Infection on Racial Differences

ABSTRACT
IgA nephropathy (IgAN) is an autoimmune disease in which IgA exclusively of the IgA1 subclass contains
altered glycan moiety and serves as an antigen recognized by naturally occurring anti-glycan antibodies mostly
of the IgG isotype, leading to the formation of nephritogenic immune complexes. The incidence of IgAN
displays a great geographical and racial distribution: the disease is common in Europe, North America,
Australia and selected Asian countries (especially Japan), but is rare in central Africa and uncommon in
countries such as India, Bangladesh, Nepal and many South American countries. Surprisingly the pronounced
racially-associated decreased incidence of the disease remains enigmatic. African Americans, African Blacks,
Australian Aborigines and probably Romanines in some countries only rarely become ill with IgAN. By
analyses of sera and cells from White IgAN patients, healthy controls and African Americans, we discovered
that the cells producing IgA1 with altered glycans are infected with the Epstein-Barr virus (EBV), which secrete
upon their terminal differentiation, IgA1 with altered glycan moiety. Importantly for our working hypothesis, in
IgAN, EBV-infected cells were detected in the IgA-positive cells from White patients, while in the healthy adult
African Americans, EBV was primarily associated with IgM/IgD and IgG-positive B cells. The reason for this
remarkable disparity was revealed through the previously disregarded difference in the maturation of the IgA
system as related to the timing of EBV infection. The levels of serum IgA and the frequency of the IgA-
producing cells are strictly dependent on the age. Children at the early age (1-5 years) have low levels of IgA
and IgA-producing cells and the adult levels are attained at puberty. However, African Americans, African
Blacks, Australian Aborigines become infected with EBV during the first 2 years of their lives. Therefore, at the
time of natural IgA deficiency, EBV infects “non-IgA-positive” cells. Indeed, we reported that in the African
American adults EBV is not dominantly found in the IgA cells! Currently, we are missing the information
concerning the characteristics of the development and maturation of the IgA system and phenotypic
characteristics of EBV-infected cells in seropositive African Americans as compared to seronegative White
children. This information is essential for the elucidation of the immunopathogenesis of IgAN and basic
clarification of racially-dependent differences. Therefore, we propose to provide experimental evidence for our
working hypothesis that the EBV infection of AA children is mainly restricted to the non-sIgA+ B cells and thus
prevents the development of IgAN. This will be accomplished by determining the differential impact of EBV on
the IgA characteristics in circulation of seropositive and seronegative AA versus White children of different
ages. In addition, we will determine how EBV infection affects the phenotype and homing potential of IgA cells
from peripheral blood of seropositive AA children.

Public health relevance
NARRATIVE Immunoglobulin A (IgA) nephropathy (IgAN) is an autoimmune disease and the most frequent glomerulonephritis in the USA, Europe, Australia and Asia, especially Japan. The disease display a characteristic racial distribution: it is common in Whites in these countries but rare in African Blacks and uncommon in African Americans, native Australians and in several Asian countries. Based on the studies of properties of IgA in patients with IgAN, and the differences in the timing in the maturation of the IgA system and age dependent infection with the Epstein-Barr virus (EBV) we propose that the early infection of African American children with the ensuing immune response to EBV, diminishes the incidence of IgAN in the African American population.